Brain-Restricted Kinase Inhibition with Binary Pharmacology

Glioblastoma (GBM), the most common primary malignant brain cancer, remains among the most lethal of
cancers. The mechanistic target of rapamycin (mTOR) is dysregulated prominently in GBM, however existing
inhibitors are limited by either poor target inhibition or poor pharmacology. CoPI Kevan Shokat therefore linked
the clinical TORKi sapanisertib (MLN0128) to the allosteric mTORC1 inhibitor rapamycin. This first bisteric
mTORC1 inhibitor, RapaLink-1, showed mTORC1-specific binding and blood brain barrier permeability. Like
rapamycin, this agent bound tightly to the cellular chaperone FK506 Binding Protein 12 (FKBP12), a protein we
showed to be expressed at high levels in GBM. Thus, RapaLink-1 potently blocked the catalytic ATP- and
substrate-binding site of mTOR within mTORC1, and accumulated in brain tumor cells. We showed that
RapaLink-1 was more potent than rapamycin or the TORKi sapanisertib, which we traced to its superior
pharmacokinetic profile compared to sapanisertib. We next generated a strategy to potentiate the inhibition
Rapalink-1 in GBM, while sparing mTOR inhibition outside the CNS, dosing mice with both RapaLink-1 and a
brain-impermeable FKBP12 ligand that we synthesized, called RapaBlock. This drug combination mitigated the
systemic effects of mTORC1 inhibitors but retained the efficacy of RapaLink-1 in orthotopic GBM xenografts. We
furthered this strategy by designing cell-permeable, FKBP12-dependent kinase inhibitors from known drug
scaffolds including FK-dasatinib. Outside of the CNS, these inhibitors were sensitive to deactivation by
RapaBlock, enabling brain-restricted inhibition of respective kinase targets.
A clinical bisteric mTOR inhibitor, RMC-5552 is currently in clinical trials. A GBM trial opens in 2023. Like
RapaLink-1, RMC-5552 is FKBP12-dependent. We hypothesize that 1). RapaBlock will potentiate efficacy while
decreasing peripheral toxicity of RMC-5552 in GBM, and 2). We can further develop our strategy to develop
FKBP-dependent inhibitors of other targets in GBM, including targets with liabilities outside of the CNS.
A1. Test the hypothesis that RapaBlock will enhance efficacy and reduce toxicity associated with use of
rapamycin and the clinical bisteric mTORC1 inhibitor RMC5552 in GBM.
A2. Test the hypothesis that linking FK506, a high-affinity FKBP12 ligand, to JAK1/2 inhibitors will generate an
FKBP12-dependent JAK inhibitor. STAT3 drives progression and therapy resistance in GBM. JAK inhibitors
block activation of STAT3, however hematologic toxicity limits their utility. We will generate an FKBP12-
dependent version of the clinical JAK1/2 inhibitor ruxolitinib. We will combine FK-ruxolitinib with RapaBlock as a
strategy to maximize inhibition of STAT3 in orthotopic GBM xenografts, while sparing hematological toxicities.
Successful completion develops a preclinical strategy to improve brain penetration while sparing peripheral
toxicities for kinase inhibitors; and provides the preclinical rationale to: 1). Test RMC-5552 and Rapablock in
combination in GBM, and 2). Move forward with developing both FK-ruxolitinib and RapaBlock as drugs.
1

Public health relevance
We generated the first bisteric mTOR inhibitors, demonstrated their activity in GMB preclinically, and generated a strategy to potentiate efficacy in GBM while sparing mTOR inhibition outside the CNS; by dosing mice with both RapaLink-1 and a brain-impermeable FKBP12 ligand that we synthesized, called RapaBlock. A clinical bisteric mTOR inhibitor, RMC-5552, developed by Revolution Medicines, is currently in clinical trials, with a GBM trial to open in 2023. We hypothesize that: 1), RapaBlock will potentiate efficacy while decreasing peripheral toxicity of RMC-5552 in GBM, and 2), We can further develop our strategy to develop FKBP-dependent inhibitors of other prominent targets in GBM, including targets with liabilities outside of the CNS, initially focusing on inhibitors of JAK kinases that block activation of STAT3. 1